Combinatorial signal integration in the maintenance and renewal of adult germline stem cell fate

Project Summary/Abstract
Throughout an organism’s lifetime, adult stem cells (aSCs) play a pivotal role in maintaining tissue
homeostasis. aSCs possess the remarkable ability to undergo asymmetric divisions, simultaneously renewing
themselves and producing differentiating daughter cells. Unlike aSCs, those daughter cells lack the capacity
for self-renewal and instead undergo terminal differentiation. Such divergent cell behaviors – asymmetric
division and self-renewal by aSCs versus symmetric division and differentiation by their daughters – suggest
that aSCs and their daughters are fundamentally distinct cell types. However, contrary to this model, daughter
cells can dedifferentiate to fully regain aSC identity, including a return to stem cell potency. Indeed,
dedifferentiation is frequently required to reestablish aSC populations after loss. These phenomena present a
fundamental paradox: how can stem cells and their differentiating progeny maintain different behaviors, yet
preserve the same potential? Notably, both these exclusively properties are clearly present in germline stem
cell (GSC) populations, and are strictly required to maintain species integrity. Drosophila male GSCs are an
exceptionally tractable model of aSC biology. In preliminary studies with this model, I discovered that
combinatorial integration of two independent signaling factors enables cells to achieve distinct behaviors while
maintaining equivalent potency. I refer to this concept as “two-factor authentication,” analogizing stem cell
maintenance to cybersecurity. Building on these preliminary discoveries, this proposal aims to
comprehensively characterize how adult stem cell systems balance regenerative plasticity with the
maintenance of discrete cell behaviors. In Aim 1, I will determine how combinatorial signals from the stem cell
niche yield distinct cellular states, including self-renewal, differentiation, and dedifferentiation. In Aim 2, I will
determine if GSCs asymmetrically retain a stemness signature that maintains their unique features. Finally, in
Aim 3, I will examine the factors involved in reestablishment of GSC fate during dedifferentiation in multiple
contexts. Expanding my prior expertise in organismal stem cell biology with advanced bioinformatic and
genetic tools will enable the completion of each of these aims. Together, these experiments defining GSC
regulation (Aim 1), identity (Aim 2), and regeneration (Aim 3) will allow for a comprehensive assessment of the
core requirements to set and maintain these exceptional stem cells.

Public health relevance
Project Narrative Adult stem cells (aSCs) underlie tissue homeostasis by maintaining self-renewal ability, without which differentiated cells will eventually become depleted, leading to tissue lesions and eventual death; conversely, aberrant upregulation of self-renewal is a driver of malignant tumor formation. How, then, is vital aSC fate regulated? In this proposal, I establish germline stem cells (GSCs) as a model for aSC biology to determine how protection of unique stem cell identity is balanced with dynamic state interconversion through the combinatorial activity of cell fate determinants.